Molecular and Temporal Dissection of Habit Learning

DESCRIPTION (provided by applicant): Impaired motor skill and habit-learning deficits have often been observed in Parkinson's disease patients well before the onset of clinically identifiable movement disorders, indicating that dopamine plays an important role in procedural habit learning. However, activities of midbrain dopaminergic (DA) neurons are regulated by cortical and subcortical signals among which glutamatergic afferents provide excitatory inputs. In this application, we set out to genetically examine the role of the NMDA receptor in the dopamine neural circuitry, namely, the ventral tegmental area and substantia nigra pars compacta as well as in the striatum in habit learning. We will generate a series of region-specific and inducible NMDA receptor knockout mouse lines to define the temporal stages during which habit is formed and stored. We will further combine conditional knockout mice with optogentic and neural ensemble recording techniques to systematically investigate the roles of the DA neuron NMDA receptor in neural dynamical patterns associated with habit learning. We believe that this integrated approach may provide us not only with important insight into the molecular and temporal mechanisms of habit learning, but also with potential novel therapeutic strategies for preventing and treating Parkinson's disease. PUBLIC HEALTH RELEVANCE: Decoding the upstream pathways regulating dopamine is crucial for understanding habit learning. This application will apply a set of molecular genetics and neural ensemble recording techniques to investigate the NMDA receptor-mediated molecular and temporal mechanisms of habit formation in the dopaminergic neural circuitry in the brain.

Public health relevance
Decoding the upstream pathways regulating dopamine is crucial for understanding habit learning. This application will apply a set of molecular genetics and neural ensemble recording techniques to investigate the NMDA receptor-mediated molecular and temporal mechanisms of habit formation in the dopaminergic neural circuitry in the brain.